Mutant p53 in Tumorigenesis, Invasion, and Metastasis

Summary
Project 1 (Lowe/Sánchez-Rivera) will integrate sophisticated genome editing, functional genomics, and
mouse modeling approaches with innovative transcriptomic and epigenomic technologies to systematically
probe the gain-of-function potential of cancer-associated mutant p53 alleles in cancer, with a particular focus
on those that influence pancreatic cancer progression and metastasis. One line of investigation will focus on
massively parallel cellular and molecular phenotyping of diverse mutant p53 alleles using a series of
technological innovations that have been established in our laboratories, including modular barcoded cDNA
libraries, optimized CRISPR base editing, and single cell genomics coupled to transcriptional profiling in a
p53 mutant-specific manner. These studies will test the hypothesis that a subset of mutant p53 alleles
produce gain-of-function phenotypes, including imparting pro-metastatic abilities to cancer cells, and that
these mutants can be molecularly classified into functional categories. In parallel, we will exploit combined
CRISPR base editing and inducible RNA interference in vivo to functionally probe the requirement for
specific mutant p53 proteins in establishing and maintaining pancreatic metastasis. Lastly, we will deploy
focused CRISPR-based high-throughput functional genomics to identify and validate p53 mutant-dependent
effectors of tumor progression and metastasis. These studies will test the hypothesis that p53 gain-of-function
alleles drive cancer progression and metastasis through a defined set of molecular programs that could be
leveraged to both classify and blunt the metastatic potential of tumors harboring specific p53 mutations. Each
of our proposed Aims are synergistic and are supported by substantial preliminary data and will benefit
from interactions with Projects 2-4 and Core 1. Successful completion of the proposed work will elucidate
at the cellular and molecular levels how p53 suppresses tumorigenesis and metastasis in vivo and may
point to more precise therapeutic opportunities relevant to a large fraction of human cancers (including
pancreatic cancer).

Public health relevance
NARRATIVE While most cancer-associated TP53 alleles disable wild type p53 function, mounting evidence suggests that some alleles can exhibit gain-of-function properties that influence cancer phenotypes beyond TP53 loss but whether, to what extent, and how TP53 mutations can have gain-of-function properties is controversial. Our proposal combines sophisticated genome editing, functional genomics, and mouse modeling approaches with innovative transcriptomic and epigenomic technologies to systematically probe the gain-of-function potential of hundreds of cancer-associated mutant p53 alleles in cancer, with a particular focus on those that influence pancreatic cancer progression and metastasis. These studies will constitute the most comprehensive foray into the investigation of the biology of TP53 mutants up to date and will serve as a roadmap for future studies of allelic variation in cancer and other diseases.